Enhancing Vaccine Thermostability with Natural Deep Eutectic Solvents

Project Summary:
We request supplemental funds to purchase a new ultralow -86°C freezer to replace one
damaged by Hurricane Ian. This freezer is critical for properly storing virus stocks, cell lines, and
vaccine formulations required to complete studies on enhancing thermostability of viral vaccines
using deep eutectic solvents, as proposed in our parent NIGMS grant.

Public health relevance
Project Narrative: This project supports purchasing an ultralow freezer crucial for storing biological materials to achieve aims of developing thermostable viral vaccine formulations, improving vaccine distribution globally.